Administrative Core

effectiveness and efficiency;it provides the necessary services for the interactions among the Cores;it coordinates the use of shared resources;it coordinates the seminar series and discussion series;it runs informal sessions to acquaint members of the Center with new techniques that bear on the research conducted by the members;it insures that there are mechanisms in place to foster collaborations;it houses a small library and conference room facility for members of the Center;its personnel and facilities aid in the preparation of grants and reports;it processes orders for all supplies and equipment related to the Cores of the Center;it provides coordination of meetings to discuss research results prior to presentation at local, national, or international meetings;it insures quality control and promotes scientific excellence throughout the Center. In short, this Core brings together all the activities that create centeredness. The Director, Co-Director, and Scientific Coordinator have worked together for over 17 years in a manner that insures a coordinated and efficient means of meeting the goals of the Center.